DTI AND FMRI FUSION TECHNIQUES FOR EPILEPSY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Depict brain plasticity tracking main bundles utilizing fMR activation patterns in epileptic patients with cortical dysplasia.